Corticospinal control of spinal reflex plasticity

Spinal cord injury (SCI), traumatic brain injury, stroke, multiple sclerosis, and other chronic disorders
produce abnormal reflexes that impair locomotion, reach-and-grasp, and other motor functions for millions of
Americans, including many Veterans. New treatments are urgently needed. Operant conditioning protocols can
change spinal reflexes in rats, mice, monkeys, and people. These protocols, which are non-invasive in
humans, can target beneficial plasticity to a specific reflex pathway. The reflex is elicited and the subject is
rewarded if the reflex satisfies a size criterion. The subject learns to modify corticospinal control over the
pathway. This control gradually changes the spinal pathway itself, and thereby triggers further beneficial
plasticity elsewhere. In people with incomplete SCI, operant conditioning of the soleus H-reflex increases
walking speed and reduces limping. The improvements persist; they are apparent to people in their daily lives.
{Reflex conditioning in people with SCI or stroke now requires 36 one-hr sessions over 12 weeks, and
is successful in only 50-70%.} Better understanding of the cortical activity that drives the reflex change should
lead to better protocols that increase the reliability, magnitude, and speed of reflex conditioning, and thereby
enhance its clinical value. This project seeks to identify electroencephalographic (EEG) features that reflect the
crucial cortical activity, to use these features to improve the reflex conditioning protocol, {and to show that this
protocol is effective in Veterans with chronic stroke.} It has two specific aims.
Aim 1 will identify EEG features that correlate will the size of the H-reflex in the arm muscle flexor carpi
radialis (FCR) and incorporate these features into the operant conditioning protocol. Based on human and
animal data, we expect that the best feature will be sensorimotor rhythm (SMR) amplitude over contralateral
sensorimotor cortex (SMC) in the 1 sec immediately before H-reflex elicitation. The new protocol will require
that this EEG feature satisfy a size criterion prior to H-reflex elicitation. We expect that this new requirement
will guide the person to produce, maximize, and maintain appropriate change in corticospinal influence on the
reflex pathway; it will thereby increase the reliability, magnitude, and speed of H-reflex change. We will develop
and validate this new protocol through studies in Veterans without neurological disease.
{Aim 2 will recruit Veterans with impaired arm function due to a stroke >1 yr earlier. One group will
undergo FCR H-reflex down-conditioning with the enhanced protocol; another group will undergo down-
conditioning with the standard protocol. (We will down-condition the FCR H-reflex in these Veterans because it
is the down-conditioning protocol that would be used clinically to reduce the hyperreflexia and/or the abnormal
flexor synergy than can occur with stroke.) Because the enhanced protocol will guide the person to produce,
maximize, and maintain appropriate change in corticospinal influence on the reflex pathway, we expect that its
reliability will be higher, and that it will decrease the H-reflex more and more rapidly, than the standard
protocol. This result will validate the enhanced protocol for people with chronic stroke.}
In sum, the goal of this project is to gain new mechanistic understanding of a novel therapy and to use
this knowledge to improve the therapy. {By identifying an EEG feature that reflects the cortical activity that
drives the spinal plasticity underlying H-reflex change, and by showing that the feature can be used to increase
the rate, magnitude, and reliability of H-reflex change in Veterans with chronic stroke, this work should
augment the therapeutic value and practicality of spinal reflex conditioning.} If it is successful, it should lead to
clinical trials that evaluate the ability of this new non-invasive therapy to enhance functional recovery for
Veterans with stroke, spinal cord or brain injury, multiple sclerosis, or other chronic neuromuscular disorders. !
!

Public health relevance
Spinal cord injury, traumatic brain injury, stroke, and other disorders cause abnormal reflexes that impair walking, hand/arm control, and other actions for millions of Americans, including many Veterans. New treatments are urgently needed. We have developed a new non-invasive protocol that can change spinal reflexes over a series of 1-hr sessions. This protocol (spinal reflex operant conditioning) can improve walking in people with spinal cord injury. People walk faster and farther and limp less; they notice these improvements in their daily lives. The goal of this project is to gain new understanding of the brain processes that underlie this method, to use this new understanding to increase the speed, magnitude, and reliability of the reflex changes, and to show that this enhanced protocol is effective for Veterans with stroke. We anticipate that this work will improve understanding of this potentially important new non-invasive therapy and will lead to clinical trials that establish its ability to enhance recovery for Veterans with stroke, spinal cord or brain injury, or other disorders.!